DEVELOPMENT OF CANINE IMMUNOTHERAPY TARGETED AGENTS

The Division of Cancer Treatment and Diagnosis, NCI is requesting support for the development and production of canine-specific agonists and/or antagonist antibodies to support immunotherapy studies in companion canines